Modulation of cytomegalovirus replication by the viral temperance factor RL13

Project Summary
Human cytomegalovirus (CMV) is a β-herpesvirus exquisitely adapted to horizontally transmit in the face of
robust preexisting immunity, replicate while causing minimal damage, maintain life-long latency, and reactivate
sub-clinically to reach new hosts. Central to this strategy of coexistence with the host are virally-encoded
“temperance factors” that actively restrict CMV replication and spread. The RL13 temperance factor, a virion-
associated envelope glycoprotein, is clearly important in vivo as an intact RL13 gene is present in all CMV
genomes sequenced from clinical materials. In cell culture RL13WT CMV isolates initially form small foci that
grow slowly with little or no release of infectious virus into the culture medium. However, within a few cell
culture passages mutations that disrupt RL13 invariably emerge and quickly outgrow the RL13WT parental
virus. Consequently, the vast majority of CMV strains used for research are RL13null mutants.
How and why RL13 represses CMV replication remain unknown. Our overarching hypothesis is that in vivo
RL13 is turned on or off to modulate CMV replication in different settings. Thus, RL13 may be turned off
at sites of entry to enhance spread and promote dissemination, then turned on during the convalescent phase
to limit the production of cell-free virus that would be rapidly inactivated by neutralizing antibodies, then again
turned off at sites of virus shedding (kidney and salivary glands) in order to drive high level release of cell-free
virus into urine or saliva for transmission to new hosts.
Recent studies have identified amino acid substitutions in the CMV glycoprotein M (gM) and Immediate Early 2
(IE2) proteins that independently counteract the temperance effects of RL13. We hypothesize (i) that RL13
repression is mediated through interactions with gM that alter virion morphogenesis, egress, or infectivity; and
(ii) that under different circumstances or cell types in vivo, RL13 transcription is activated or repressed by cell
type-specific expression of certain IE2 isoforms. These hypotheses will be explored through the following Aims:
AIM 1. Determine the mechanism by which RL13 restricts CMV replication. Genetic and molecular
techniques will be used to explore potential interactions between RL13 and gM to elucidate the molecular
mechanisms whereby RL13 impairs assembly and/or release of infectious CMV virions.
AIM 2. Determine how IE2 isoforms modulate RL13 temperance activities. Genetic and molecular
approaches will determine how amino acid substitutions in IE2 or altered expression of IE2 isoforms impact
RL13 expression or repression.
RL13 has a seemingly paradoxical but clearly important role in the natural history of CMV infections. The
proposed studies may reveal that RL13 is a “master regulator” that can be activated or repressed to control
virus production as circumstances in vivo require. The results will be among the first to elucidate the functional
basis of viral proteins that restrict, rather than enhance, viral replication and spread.

Public health relevance
Project Narrative How and why the viral temperance factor RL13 restricts cytomegalovirus replication remains unknown. The proposed studies will determine the molecular interactions and mechanisms that mediate the repressive effects of RL13 and modulate RL13 expression. These results will be among the first to elucidate the mechanisms whereby certain viral proteins restrict, rather than enhance, viral replication and spread.